Deciphering the roles of COMPASS-related methyltransferases in intellectual and developmental disability

Project Summary
Roughly 1,000 genes have been associated with intellectual and developmental disability (IDD), but targeted
treatment options are lacking. Despite this genetic heterogeneity, many implicated genes have similar functions,
suggesting they converge on shared mechanisms. There is a critical need to identify potential convergent
mechanisms to develop therapeutics for each subclass of genes associated with IDD. This proposal focuses on
six related chromatin regulators to determine whether IDD-causing mutations in these genes affect similar
molecular pathways. These six SET methyltransferases (SETD1A, SETD1B, KMT2A, KMT2B, KMT2C, and
KMT2D) each form a separate COMPASS complex that methylates H3K4. Haploinsufficiency of each gene
causes a separate neurodevelopmental syndrome with intellectual disability as a feature. My central hypothesis
is that mutations in these COMPASS-related methyltransferases cause intellectual and developmental disability
through dysregulating a shared set of genes due to changes in H3K4 methylation patterns. The alternative
hypothesis is that IDD results from broad gene expression dysregulation of non-overlapping gene sets. The
proposed aims will test both hypotheses and the data I will generate will provide new insight into mechanisms
driving IDD irrespective of the outcome.
I will use a robust CRISPR interference-based platform in human induced pluripotent stem cells (iPSCs) to
knockdown and study these six COMPASS-related genes. In Aim 1, I will elucidate dysregulated molecular
pathways due to haploinsufficiency of COMPASS methyltransferases via transcriptomic and epigenomic
profiling. These data will allow me to test the hypothesis that loss of these genes leads to dysregulation of similar
gene sets and determine whether these similarities can be explained by shared genomic binding sites. In Aim 2,
I will functionally characterize morphological and neurophysiological effects of COMPASS methyltransferase
haploinsufficiency on human iPSC-derived neurons. These experiments will reveal either common or divergent
signatures at the cellular and network levels and will provide insight into the pathophysiology of intellectual
disability. This proposal is significant because it will establish a framework to elucidate convergent mechanisms
in IDD that could be scaled to a broader set of genes in future studies. My fellowship proposal also outlines a
rigorous training plan focused on five specific areas to support my long-term career goal of becoming an
independent investigator: (1) identifying interesting research questions and designing rigorous experiments; (2)
effective scientific communication in oral presentations, manuscript writing, and grant writing; (3) novel research
techniques, including CRISPR methods, stem cell culture, calcium imaging, and chromatin profiling; (4)
mentoring students and collaborating with colleagues; and (5) preparation for an independent career. Through
direct supervision from Dr. Huda Zoghbi and Dr. Zhandong Liu, I will be immersed in an extremely collaborative
and supportive training environment at Baylor College of Medicine.

Public health relevance
Project Narrative Chromatin regulators represent a major class of genes implicated in intellectual and developmental disabilities (IDD), but whether these genes cause disease through similar mechanisms remains unknown. The proposed project uses multi-omics and neurophysiology methods to elucidate genomic binding sites, dysregulated gene sets, and altered neuronal firing patterns associated with haploinsufficiency of six COMPASS-related methyltransferases associated with IDD. This work will reveal whether these genes converge on shared molecular mechanisms that could serve as therapeutic targets and will provide a proof-of-concept for a broadly applicable framework for discovering convergent pathways in IDD in future studies.